Investigating the mechanisms of erythroid lineage commitment in hematopoietic stem and multipotent progenitor populations

PROJECT SUMMARY/ABSTRACT
Elucidating the underlying mechanisms of lineage specification is not only a fundamental question of biology but
also has a critical implication in therapeutic purpose. How initial erythroid lineage specification occurs in adult
hematopoietic stem and multipotent progenitor populations has been largely unappreciated despite of its
potential clinical significance to efficiently modulate erythroid cell production. Recent discoveries of lineage bias
in hematopoietic stem cells (HSCs) and multipotent progenitors (MPPs) raises an intriguing possibility that early
erythroid lineage priming occurs in HSC and MPP levels. This proposal aims to uncover the earliest erythroid
lineage commitment events and their underlying mechanisms in HSCs and MPPs by investigating key extrinsic
and intrinsic factors. First, I will identify the signaling pathways that are activated during the generation of
erythroid cells in HSCs and MPPs using various in vitro and in vivo methods. Second, the role of endoplasmic
reticulum (ER) stress signaling in erythroid lineage priming of MPP3 will be tested by molecular, cellular, and
pharmacological approaches. Third, epigenetic regulation of erythroid priming in MPP2 will be investigated using
omics analysis. This work will be conducted in the laboratory of Dr. Emmanuelle Passegue, internationally
renowned HSC biologist and the director of the Columbia Stem Cell Initiative at Columbia University. My long-
term career goal is to establish my independent research program constructing lineage specification networks
of the blood system. To achieve this goal, as a first step, I will broaden my intellectual knowledge base and
increase my technical skill repertoire through additional coursework/workshop/meetings and hands-on training.
To aid in this process, I have assembled a mentoring and scientific advisory committee consisting of
internationally renowned scientists with expertise in different areas relevant to my research and career goals.
Collectively, the proposed studies will provide significant insight into the mechanisms of early erythroid lineage
commitment and offer potential new strategies to control erythroid cell production. Moreover, this work will
provide me with a solid foundation to establish my unique research program.

Public health relevance
PROJECT NARRATIVE Anemia, a condition caused by a lack of healthy red blood cells, can affect individuals with varying degrees from interfering with daily activities, worsening patients’ chronic disease including cancer, to life-threatening. This project investigates the poorly understood initial process of erythroid lineage priming in hematopoietic stem and multipotent progenitor cells and the underlying mechanisms. This research will provide a foundation for novel intervention strategies to modulate red blood cell (erythrocyte) production in stress and disease conditions.